CORE--INFORMATICS

The purposes of the Informatics Core are: 1.To provide assistance to each project in the gathering, and maintenance of data; 2. To facilitate the sharing of data and results between projects; 3. To provide assistance to individual projects in the analysis including biostatistical analysis of data and the planning of experiments and studies; 4. To assist in the design and analysis studies from collaboration between the individual projects. The specific aims of the Informatics Core are as follows: 1. To provide the statistical analysis required to achieve the specific aims of each project; 2. To assist in the design of new research arising from individuals projects; 3. To assist in the exchange of information and results between projects; 4. To aid in the design and analysis of new studies arising from such collaborations; 5. To supervise and coordinate the collection of data for each project; 6. To assist in the collection, entry, and maintenance of data specific to each project; 7. To facilitate the transfer of data between projects; 8. To maintain connectedness of data bases through the use of a central data base containing minimal information on all patients enrolled in any project; 9. For all clinical trials to provide for rigorous data management, quality assurance, auditing procedures, and confidentiality of clinical data.